Nebulized ALX1 as a Treatment for Difficult Non-tuberculous Mycobacterial Lung Infections

SUMMARY
Non-tuberculosis mycobacteria (NTM) infections are currently treated with a multiple antibiotic regimen
that often fails to result in sputum culture conversion. In fact, culture conversion rates remain less than 50%
despite treatment periods over 12 months, highlighting the refractory nature of the disease. In individuals
with compromised lung function (e.g., bronchiectasis), infection often leads to NTM pulmonary disease
(NTM-PD) and severe lung function decline over time. Repeated use of unsuccessful antibiotic regimens
engenders antimicrobial resistance (AMR), further reducing treatment options and impacting morbidity.
New antimicrobial therapies to effectively treat NTM-PD without promoting AMR are greatly needed.
Nitric oxide (NO) is an endogenous broad-spectrum antimicrobial agent produced by the immune system
(i.e., macrophages and neutrophils) in response to pathogens. In certain diseases, the levels of naturally
produced NO are often inadequate to elicit a successful response. The innovative delivery of water-soluble
NO-releasing prodrugs via inhalation provides a means for delivering NO locally into the lungs in a
controlled manner while limiting off-target effects. In published studies, we have demonstrated the in vitro
and in vivo (preclinical) potential of our NO-releasing formulation to treat Mycobacterium abscessus. Our
drug candidate, ALX1, is unique in that it enables nebulization of a low molecular weight NO prodrug that
has potent broad-spectrum antibacterial activity with no documented resistance to date.
The objective of this SBIR Phase II project is to evaluate the pharmacokinetics and optimize the dosing
regimen of inhaled ALX1 needed to inform dose selection for a Phase 2 proof-of-concept clinical trial in
NTM-diagnosed bronchiectasis patients. Specifically, we seek to: 1) determine the dose proportionality and
relationship between local lung and systemic plasma concentrations of the NO-releasing prodrug following
inhalation in rodents and, 2) demonstrate the optimum pharmacologic effect of ALX1 formulation to treat
M. abscessus infections in rodents when delivered via inhalation, either once or twice daily. Upon completion
of these objectives, we will be positioned with information to successfully translate efficacious ALX1 doses
in animals to predicted effective doses in bronchiectasis patients.

Public health relevance
NARRATIVE Non-tuberculosis mycobacteria (NTM) pulmonary infections in individuals with bronchiectasis are particularly challenging to overcome because the pathogens invade immune cells, reside deep within the lung, and engender antibiotic resistance. Vast Therapeutics is developing ALX1, a novel nebulized formulation of a nitric oxide-releasing prodrug to treat difficult NTM infections including those caused by Mycobacterium abscessus. In this Direct-to-Phase II SBIR project, our objective is to evaluate the pharmacokinetics and optimize the dosing regimen of inhaled ALX1 against M. abscessus infection in preclinical models needed to inform dose selection for a future Phase 2 clinical trials in bronchiectasis patients.